Core--Experimental design and research data analysis

The purpose of Core Component C is to provide expertise and resources for biostatistical planning and analysis of laboratory and clinical experiments. The Experimental Design and Data Analysis Core will provide biostatistical support to the entire PROGRAM PROJECT.